Identifying modifiable factors that reduce the burden of late stage melanoma in Hispanics

Project Summary
Hispanics are diagnosed with melanoma at later stages than their non-Hispanic white (NHW) counterparts,
leading to increased likelihood of metastasis and worse survival. Hispanics are the largest ethnic group in the
United States and have rising rates of melanoma, and in particular, increases in tumors with the worst
prognosis. Hispanics represent an underserved and understudied population when it comes to melanoma
occurrence and outcome. In our recent analysis, while the risk of presenting with a late stage melanoma was
higher for Hispanics (OR:1.65 [95% CI:1.52-1.79]) than NHW, the overall risk of death from melanoma after
accounting for stage at diagnosis was similar for Hispanics and NHW (HR: 0.99 [95% CI: 0.94-1.04]), implying
that the overall poorer prognosis for Hispanics is due almost entirely to their later stage of disease at diagnosis,
rather than response to treatment or other factors (e.g. ability to access treatment) once they are diagnosed. A
later stage of diagnosis among Hispanics could be due to a multitude of factors all of which are modifiable: a
lack of access to appropriate screening, lack of adherence to screening recommendations, lack of
understanding of appropriate screening approaches in the primary care setting (among both patients and
physicians), or a combination of these factors. The key question remaining to be answered is WHY Hispanics
are diagnosed at a later stage: without answering that question, we cannot begin to design, test and implement
effective interventions to improve earlier detection and reduce melanoma-related disparities for Hispanics. We
will investigate modifiable factors related to diagnosis at later stage in Hispanics compared to NHW.
Aim 1: Determine the roles of patient-perceived risk and knowledge of melanoma, perceived barriers to
melanoma screening and diagnosis, patient access to screening and diagnosis, and cultural factors in
determining the later stage at diagnosis of melanoma in Hispanic compared to NHW melanoma patients.
Aim 2: Determine how, when and by whom melanomas are diagnosed (among Hispanics and NHW) and what
factors are related to time delays in the diagnosis of melanoma.
Aim 3: Develop, deliver and test a clinic-based health education telenovela intervention designed to achieve
earlier diagnosis of melanoma among Hispanics.
We will obtain data from multiple sources for this study in order to minimize the potential impact of selection,
response and survival biases all of which would compromise the scientific rigor of our Approach. We will
identify the key factors resulting in late diagnosis of melanoma among Hispanics to provide truly population-
based data on HOW to develop targeted patient-and-systems level interventions to reduce the melanoma
burden among Hispanics. We will then test targeted patient-and-physician level interventions carried out in low
income primary care setting ensuring that we intervene at the earliest possible stage.

Public health relevance
Narrative Hispanics are diagnosed with melanoma at later stages than their non-Hispanic white (NHW) counterparts, leading to increased likelihood of metastasis and worse survival. We will investigate a number of modifiable factors likely to be related to diagnosis at later stage in Hispanics compared to NHW. The study will be carried out in Los Angeles County which has the required population-based cancer registry, high rates of melanoma among Hispanics, and factors likely to be related to delayed diagnosis that represent those seen throughout the U.S.